The UC Davis enhanced Molecular, Cellular, and Developmental Biology Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The primary goal of the UC Davis enhanced Molecular, Cellular, and Developmental Biology (eMCDB) Training Program is to ensure the success of our predoctoral Trainees in graduate school and prepare them for impactful careers in the biomedical workforce by nurturing productive, rigorous, resilient scientists and confident communicators. A secondary goal of the eMCDB Program is to enhance the training and career development of a broad cohort of PhD students at UC Davis by extending our activities beyond our Program. A dynamic and experienced team of 63 Faculty Trainers from 18 academic departments will provide our training. These trainers, carefully selected from the top molecular, cellular, and developmental biologists on campus, offer wide-ranging interdisciplinary training in basic and translational life science research. Each has an active research program, a successful track record of mentoring, and a commitment to fostering safe and supportive training environments. Trainees are selected from the most qualified graduate students across five affiliated Graduate Groups through a comprehensive process. Training is accomplished by integrating Graduate Group coursework and mentored PhD dissertation research in individual laboratories with a coherent set of curricular and training activities developed by this Program to support each Trainee’s growth along five skillsets critical for graduate training and lifelong career progression: scientific rigor, communication, wellness and resilience, mentoring, and career development. The effectiveness of our Program’s activities will be regularly and rigorously evaluated to allow Program leadership to adapt and ensure that Program goals are met. Institutionally, UC Davis has made major commitments to establish a vibrant faculty and cutting-edge infrastructure to support research in molecular, cellular, and developmental biology. The substantial institutional support allocated to this Training Program further reflects our shared goals to deliver outstanding, high-quality graduate training for eMCDB Trainees and our commitment to support the development of the national biomedical research workforce.

Public health relevance
The UC Davis enhanced Molecular, Cellular, and Developmental Biology (eMCDB) Training Program will provide high quality predoctoral training to its Trainees and prepare them for impactful careers in the national biomedical workforce. This will be accomplished by a coherent set of enhanced training activities aimed at nurturing productive, rigorous, resilient scientists and confident communicators.